Alaska Conformance with the Voluntary National Retail Food Regulatory Program Sta

Project Summary/Abstract The State of Alaska Food Safety and Sanitation Program (FSS) provides direct public health and regulatory oversight of manufactured food establishments, retail food establishments, public facilities, and shellfish shippers, producers, and processors throughout Alaska. In January 2005, Alaska enrolled in the Voluntary National Retail Food Regulatory Program Standards (VNRFRPS), recognized critical elements in creating a national, fully integrated food safety system by establishing a uniform basis for measuring and improving the performance of retail food programs in the United States. Conformance with these standards assists both federal and state programs in better directing their regulatory activities at reducing foodborne illness hazards in retail food establishments. Alaska has assessed its program and has developed a comprehensive strategic plan to continuously improve program areas that do not meet a particular standard with the intention of achieving full conformance by year five of this proposed cooperative agreement. Under this proposed cooperative P¿ u v¿Uo ¿l [¿} i ¿]¿ ¿ ¿ ¿}(}¿¿ ¿}¿¿¿ Z¿}]v ¿¿¿¿¿U^¿ v ¿ ]¿ ¿¿ ((U v complete the Risk Factor Survey 3. Additionally, Alaska will perform comprehensive self-assessments, updating its strategic plan accordingly, and fully participate in initiatives supporting the VNRFRPS with the goal of implementing a risk-based program that continuously improves over time.

Public health relevance
Project Narrative The Voluntary National Retail Food Regulatory Program Standards (VNRFRPS) are recognized critical elements in creating a national, fully integrated food safety system that are intended to enhance food safety by establishing a uniform basis for measuring and improving the performance of retail food regulatory programs in the United States. Conformance with these standards assists both federal and state programs in better directing their regulatory activities at reducing foodborne illness hazards in retail food establishments. Consequently, the safety and security of the United States food supply will improve. __SpecificAimsTextDelimiter__ Specific Aims Goals of Proposed Project • Advance efforts for a nationally integrated food safety system by developing and implementing a comprehensive strategic plan that will result in significant to full conformance with the VNRFRPS and sustainability after the cooperative agreement ends. • Implement a risk-based food safety program by participating in standards that provide a uniform basis for measuring and improving Alaska's retail food regulatory program. • Fully participate in initiatives supporting the VNRFRPS, such as meetings, committees, conference calls, sharing of best practices, annual on-site visits, program assessment validation audits, and full program audits. • Have adequately trained staff and the criteria and ability to hire and/or train personnel to meet the deliverables of the cooperative agreement. Summary of Expected Outcomes • Achieve and sustain significant to full conformance with the VNRFRPS, a set of standards recognized as a critical element to creating a national, fully integrated food safety system. • Contribute to the continuous improvement of the VNRFRP through attendance meetings and active participation in committees supporting VNRFRP. • Develop strategies for achieving and sustaining conformance with the VNRFRP that can be duplicated on a national basis. • Provide FDA the foundation for pursuing regulatory action based upon the findings of Alaska's retail food regulatory program. Result of Proposed Project Significant to full conformance with the VNRFRPthat is sustainable after the cooperative agreement ends resulting protection of the public's health from foodborne illness and injury.